Identification of new genetic causes of congenital neutropenia

The long-term goal of this of this research is to identify new genetic causes of congenital neutropenia and
characterize their molecular mechanisms of disease pathogenesis. Severe congenital neutropenia (SCN) is an
inborn disorder of granulopoiesis characterized by severe chronic neutropenia from birth, premature death
secondary to infectious complications, and transformation to myeloid malignancy. Approximately one-third of
cases do not have a known genetic cause. We performed whole exome sequencing of 85 cases of congenital
neutropenia. Heterozygous missense mutations of CLPB, encoding caseinolytic peptidase B, were identified in
6 of 45 (13%) ELANE-negative SCN cases; we subsequently identified heterozygous CLPB mutations in an
additional 3 cases of SCN that were not part of our original cohort. CLPB encodes for caseinolytic peptidase B,
an ATPase implicated in protein folding and mitochondrial function. Prior studies showed that biallelic mutations
of CLPB are associated with a syndrome of 3-methylglutaconic aciduria, cataracts, neurologic disease, and
variable neutropenia. However, these mutations are distinct from those seen in our series, which are
heterozygous and cluster near the ATP binding pocket. Preliminary data show that CRISPR-Cas9 gene editing
to inactivate CLPB or lentiviral-mediated overexpression of mutant CLPB in human CD34+ cells results in
impaired granulocytic differentiation. Collectively, these data suggest that heterozygous mutations of CLPB
are a new and relatively common cause of SCN. In this proposal, we will examine molecular mechanisms by
which mutant CLPB disrupts granulopoiesis. We also will identify and biologically validate, using a similar
approach, other potential neutropenia-causing gene mutations identified by current and ongoing sequencing of
congenital neutropenia cases. The following specific aims are proposed.
Aim 1: To define the spectrum of CLPB mutations that disrupt granulopoiesis. We will use lentiviral-
mediated overexpression in human CD34+ cells to systematically assess the impact on granulopoiesis of
CLPB mutations identified in patients with congenital neutropenia, including the biallelic mutations found in
syndromic cases.
Aim 2. To characterize mechanisms by which mutations of CLPB disrupt granulopoiesis. We will test
the hypothesis that mutant CLPB acts in a dominant fashion to disrupt the chaperone function of CLPB, resulting
in impaired activation of the mitochondrial unfolded protein response (UPRMT) and induction of apoptosis in
granulocytic precursors.
Aim 3. To identify and validate new genetic causes of congenital neutropenia. We will perform exome
sequencing of at least 100 additional cases of congenital neutropenia with no known cause. These data will be
interrogated to identify candidate genes for functional validation.

Public health relevance
Patients with a reduced number of neutrophils in their blood (termed neutropenia) are at an increased risk for bacterial infections. The goal of this research is to identify new genetic causes of congenital neutropenia and to understand how these mutations disrupt normal neutrophil production. This research will facilitate the rapid diagnosis of patients presenting with neutropenia, improve our understanding of how neutrophil production is regulated, and suggest new strategies to prevent or treat neutropenia.